Full Gene Replacement for Hemophilia A Enabled by the StitchR Technology

ABSTRACT
Hemophilia A (HA) is a common sex-linked bleeding disorder affecting ~ 1 in 4,000 male births in
the United States, caused by loss-of-function mutations in the Factor VIII (FVIII / F8) gene that
disrupt blood coagulation. Conventional treatments, such as recombinant FVIII protein and
bispecific antibodies, require frequent administration. Recently, adeno-associated virus (AAV)-
mediated gene therapy, which delivers a truncated B domain-deleted FVIII (BDD-FVIII) from the
liver, has received FDA approval and shown promise in reducing bleeding events. However, the
B domain, while not essential for clotting, is important for FVIII stability and secretion, and BDD-
FVIII has been associated with hepatocellular carcinoma (HCC) in some preclinical models.
Gene-replacement therapy presents a potentially curative alternative, but AAV's limited cargo
capacity has so far restricted clinical testing to truncated FVIII versions, resulting in limited
efficacy. To overcome these challenges, we propose the development of a novel dual AAV vector
technology, StitchR, which utilizes ribozyme-activated RNA trans-ligation to deliver and express
full-length FVIII. This approach addresses AAV's size limitations and aims to provide targeted,
stable, and non-mutagenic FVIII expression. Our preliminary data indicate that StitchR can
successfully be used to trans-ligate and express full-length FVIII in vitro. The proposed research
will advance this technology by engineering robust AAV constructs for FVIII gene delivery,
evaluating different tissue-specific promoters to optimize FVIII expression and durability, and
assessing therapeutic and unintended host responses using a human-FVIII tolerant mouse model
of HA. This project aims to validate a new approach for large gene-replacement therapies for
blood disorders, establish a foundation for future research in higher mammals, and provide a best-
in-class treatment for HA in patients.

Public health relevance
Narrative Recent clinical research indicates that gene therapy has the potential to cure hemophilia A, a bleeding disorder affecting 1 in 4,000 male births globally. Despite this promising development, challenges persist with the adeno-associated virus (AAV)-mediated gene therapy that utilizes a truncated B domain-deleted FVIII (BDD-FVIII). Our proposed project seeks to validate a novel approach for large-scale gene-replacement therapies for blood disorders, aiming to deliver a superior treatment for hemophilia A patients.